Evaluating the Impact of Medicaid Dental Coverage on Early-Stage Oral Cancer Detection

ABSTRACT
Oral cancer kills more than 10,000 adults each year. Earlier detection could improve survival and quality of
life, but less than 30% of oral cancers are detected at early stages. While previous research has investigated
whether access to health insurance could lead to earlier detection, my preliminary evidence suggests these
previous studies miss a critical feature of oral cancer control: access to dental services. Physicians are not
recommended to systematically screen for oral cancer, whereas dentists routinely screen for oral cancer as
standard of care. My preliminary findings affirm the critical role of dentists in oral cancer control systems. Yet,
despite the importance of dental services for detecting oral cancer early, low-income adults face financial
barriers to accessing dental services. In fact, the lack of affordable dental coverage leads adults to delay or forgo
necessary dental care more than any other healthcare service. Medicaid has filled the dental coverage gap for
many adults, but states are not required to provided dental benefits to their adult Medicaid beneficiaries.
Consequently, adult Medicaid dental programs have changed over time and vary by state. The volatility of
Medicaid dental coverage could be further exacerbating delays in oral cancer detection for low-income adults.
To inform policies improving population oral health, this proposal evaluates the impact of
access to Medicaid dental services on early-stage oral cancer. Under guided mentorship, I will be
among the first to evaluate Medicaid dental policies by analyzing population-based cancer registry data. This
novel data includes verified Medicaid enrollment indicators, allowing me to select a valid sample of low-income
adults. Aim 1 hypothesizes that Medicaid enrollees exposed to a change in state-level Medicaid dental coverage
will change their probability of being diagnosed with oral cancer at an early-stage. Using advances in causal
inference methodology, this aim leverages the longitudinal and state-by-state variation of adult Medicaid
dental policies to avoid selection bias confounding our estimates. Next, we aim to infer an effect of access to
Medicaid dental services on early-stage diagnoses by accounting for county-level dentists per capita. Aim 2
hypothesizes that the effect of changing Medicaid dental coverage on the probability of an early-stage diagnosis
is mediated by the number of available dentists. Both research aims will improve the field’s knowledge of oral
cancer disparities by identifying heterogenous effects and testing for effect differences across cancer
characteristics, sociodemographic factors, and rurality status. By quantifying how access to dental coverage and
dental providers affects early-stage oral cancer diagnoses, our evidence will advance policies aiming to control
and prevent oral cancer mortality by increasing early detection. Future research can then identify how to
alleviate any remaining early-stage oral cancer detection gaps. Collaborating with my interdisciplinary research
team at the University of Iowa College of Public Health and College of Dentistry will advance my career as an
independent investigator.

Public health relevance
PROJECT NARRATIVE Detecting oral cancer earlier could improve survival and quality of life for low-income adults vulnerable to the disease. Given that oral cancer is most likely to be diagnosed early after a screening by a dental professional, this study uses newly released population-based cancer registry data to investigate how access to dental services impacts early detection for oral cancer patients enrolled in Medicaid. The evidence examining the effect of dental coverage on the timing of oral cancer detection will highlight the potential value of expanding dental services to low-income adults, as well as illuminate potential dental health policies to reduce the excessive burden of late-stage oral cancer.